ALZHEIMER'S DISEASE BEFORE PLAQUES AND TANGLES: Abeta-AMYLOID OLIGOMERS AND THE GLYMPHATIC PATHWAY

PROJECT SUMMARY There is substantial evidence that soluble Aβ oligomers are neurotoxic and that impaired clearance of soluble Aβ is a critical pathologic mechanism in late-onset AD, a concept supported by the observation of decreased passage of Aβ into the cerebrospinal fluid (CSF) in AD6 and the decreased levels of Aβ in the CSF of AD patients. The mechanisms for clearance of extracellular Aβ from the brain are multiple and include local enzymatic degradation, transport across the blood brain barrier (BBB), or via the CSF. The relative contributions of these various systems to Aβ clearance are not fully understood, although the BBB system appears to be predominant. However, recently, the glymphatic system has been implicated in this process, possibly in addition to BBB mechanism. The glymphatic system is proposed as a brain waste clearance pathway consisting of perivascular tunnels lined by astrocytes that drain into CSF and eventually into cervical lymphatic nodes. This system allows for the elimination of soluble proteins and metabolites from the central nervous system and it may be implicated in Aβ clearance and the development of AD. The clearance efficiency of the glymphatic system depends on CSF flow, cerebrovascular pulsation, and the aquaporin-4 (AQP4) water channels of perivascular astrocytes. In mice, the efficiency of the glymphatic pathway appears compromised in aging due to impairment of AQP4 dependent bulk flow. The role of the glymphatic system in the clearance of Aβ and its relevance to AD is based mostly on studies in rodents, which is one of the reasons why it remains controversial. Therefore, the relevance of the glymphatic system to AD needs to be examined in the human brain, which is the overall goal of this proposal. Moreover, we believe that the best time to conduct this examination is before and during the early stages of Aβ deposition. To this end, we have available a large number of human postmortem brains from individuals 30 to 65 years of age which are fully characterized for AD lesions and tissue integrity, and genotyped for ApoE. The exploratory and observational studies proposed here are the basis for future mechanistic examination of the glymphatic system and its relevance to AD to be conducted in cultured cells and tissues, and animal models.

Public health relevance
PROJECT NARRATIVE This exploratory study is relevant to public health for two reasons. It has the potential to generate novel information on the very early development of Alzheimer’s disease and in this way can help us to identify new biomarkers and inform on both the nature of and best timing of interventions for prevention and treatment.